A cerebellar synaptic mechanism for temporally precise behaviors

PROJECT SUMMARY/ABSTRACT
An important feature of the brain is its ability to combine information about the external environment with internal
state in order to generate precisely timed actions. These processes occur on varying timescales and involve
different parts of the brain, but the cerebellum is central to shaping sub-second behaviors. Damage to the
cerebellum can affect the timing of a conditioned eyeblink and can cause diminished movement endpoint
accuracy and oscillatory movements around a target. While considerable work has focused on how cerebellar
output can fine-tune movements, it is not known how the cerebellum generates precise temporal representations.
This proposal leverages the well-defined structure of the cerebellum and novel optical tools to examine how the
synaptic properties of the cerebellar circuit might underlie precisely timed behavioral outputs.
Cerebellar granule cells integrate mossy fiber inputs that carry information from different cortical and subcortical
streams and that have diverse short-term dynamics. To investigate whether this synaptic diversity generates
sub-second temporal representations, genetically encoded calcium, glutamate, and voltage indicators will be
used to measure mossy fiber and granule cell activity while mice are performing a skilled reaching behavior that
requires temporal precision. Mossy fiber and granule cell activity will be compared to mossy fiber glutamate
release to test the hypothesis that mossy fiber activity is transformed at the synaptic level to generate a set of
sparse, reliable, and distinct granule cell activity patterns, i.e. a temporal basis set. To test the hypothesis that
short-term plasticity dynamics at mossy fiber-granule cell synapses underlie temporal patterns of granule cell
activity, a light-activated G-protein-coupled receptor will be used to lower mossy fiber release probabilities. The
synaptic consequence of this will be measured using ex vivo whole-cell recordings of granule cells. Further, the
effect of altering mossy fiber release probabilities on in vivo granule cell temporal dynamics and on reach
endpoint accuracy will be assessed.
These findings will elucidate how synaptic diversity can subserve temporal computations in the cerebellum and
may provide a more generalizable principle for how synaptic diversity can drive patterns of activity.

Public health relevance
PROJECT SUMMARY/ABSTRACT The cerebellum is known to support temporally precise actions occurring on the sub-second timescale, but how it generates these temporal representations is not known. In this proposal, I study how diversity at the level of synapses can give rise to behaviorally relevant temporal patterns of neural activity. These findings may provide a more general principle for understanding how information at the level of the synapse can be transformed to generate population neural dynamics.